NRSA Training Core

PROJECT SUMMARY: TL1 TRAINING PROGRAM
Addressing the shrinking clinician-scientist workforce depends on the early recruitment of potential trainees
along the clinical and translational training continuum. To address the future workforce needs in the Midwest
and across the nation, the Frontiers TL1 program will continue to provide high-quality training in clinical and
translational research to a diverse group of trainees. This region needs additional researchers who can make
national contributions to translational science while bringing new discoveries to the communities and patients,
including those who are underserved and excluded.
Aim 1. Reinforce the clinician-scientist pipeline by recruiting a highly qualified, dedicated and diverse
pool of TL1 predoctoral and postdoctoral trainees to build the translational workforce
In Frontiers 1.0, we demonstrated success in recruiting pre-doctoral clinical trainees. During Frontiers 2.0, we
expanded the training tracks to include 4 post-doctoral trainees per year. In Frontiers 3.0 we will focus on
recruitment of trainees who are underrepresented in clinical and translational research and whose research
focus is on underserved and excluded populations.
Aim 2. Enhance team science in translational science workforce development through the utilization of
experienced and skilled multidisciplinary mentorship teams across Frontiers partners
We have expanded the list of experienced and funded mentors from multiple programs across the Frontiers
institutions who are willing and capable of providing mentorship. These senior and mid-career mentors, along
with newly added junior mentors, already work in interdisciplinary, translational research teams and will
effectively demonstrate to our TL1 trainees the values of team science and collaborations built between
institutional partners.
Aim 3. Build upon our existing novel and competency-based clinical and translational research
curricula
Our established, comprehensive, and successful Frontiers Training program will provide TL1 trainees with
critical competencies to successfully conduct translational research. We will complement that degree program
with a variety of innovative short term and non-degree training opportunities that address the needs of our
trainees and map to skills needed to launch independent research careers.
Aim 4. Implement more rigorous individualized evaluation methods integrated with trainee
individualized development plans to track success and enrich the training environment with efficiency
and precision
We will utilize a mixed methods evaluation plan that integrates the trainee individualized development plan to
track short- and long-term success of our trainees.